INTRON A VS INTRON A PLUS RIBAVIRIN AT 2 DOSES TO TREAT CHRONIC HEPATITIS C

This is a double-blind, placebo controlled, randomized parallel group study conducted in two stages comparing 4 levels of ribavirin (400, 600, 800 and 1000-1200 mg/day) + Intron A 3 MU TIW and Intron A 3 MU TIW + placebo in patients with chronic hepatitis C who have not previously been treated with interferon.